Evaluating antibiotic tolerance in single cells with tandem single cell measurements of translation rate and transcriptomes

Phenotypic tolerance to antibiotics is a major cause of antibiotic drug failure. Non-heritable mechanisms that
confer antibiotic tolerance have long been associated with cells that maintain a diminished metabolic rate. The
presence of a small number of cells in a low activity level within a large population of susceptible cells poses
formidable technical challenges for analysis because any bulk measurement will average out the small signal
produced by the tolerant cells with the strong signal of the larger and more active population. Single cell
measurements that can identify the activity level of single cells and link them with the transcriptomic signature of
these cells can solve this problem and address fundamental open questions about how these low activity cells
arise and persist. For starters, such measurements can determine whether cells in this state all share a signature
transcriptomic profile or if multiple different gene expression states are correlated with low activity. Additionally,
measurements of transcriptomic activity in cells that have lower activity levels can predict what metabolic genes
these cells express and pinpoint whether there are weaknesses that can be exploited therapeutically. In this
proposal we aim to first develop a single cell technique that will report the translational rate and transcriptome of
thousands of individual bacterial cells. We will then explore the level of translational and transcriptomic
heterogeneity in Staphylococcus aureus cells that were passaged in a model that mimics chronic infections and
long-term antibiotic recalcitrance. Our data will determine whether an increasing percent of the S. aureus
population is found in a low-activity state upon continuous infection and the presence of antibiotics.

Public health relevance
In many instances bacterial phenotypic heterogeneity allows a small subpopulation of cells to stay alive despite the presence of antibiotics, even when these cells do not have genetic alterations that make them antibiotic resistant in a heritable way. In several scenarios where such tolerant cells exist they pose a clinical burden, and the ability to tolerate antibiotics has been linked to a reduced cellular activity and rate of protein synthesis. In this grant we develop tools to link the gene expression of cells to their protein synthesis rates in order to understand which genes are activated by cells in the low activity state during antibiotic tolerance.